Neutrophils in Sepsis: Role of CIRP

PROJECT DESCRIPTION: This R01 project's goal is to investigate the mechanism by which cold-inducible
RNA-binding protein (CIRP) increases sepsis severity and causes acute lung injury (ALI). Sepsis and ALI are
deadly and have no FDA-approved treatment. CIRP is a nuclear protein that can be released into the
circulation during sepsis, increasing sepsis severity and causing ALI. We have discovered that CIRP
increases a novel subset of neutrophils characterized by surface expression of intercellular adhesion molecule-
1 (ICAM-1). We found that ICAM-1+ neutrophils were expanded in the blood and lungs of septic mice, but not
in CIRP knockout mice. We further showed that stimulation with CIRP was sufficient to induce ICAM-1+
neutrophils. For the first time, we discovered that CIRP-induced ICAM-1+ neutrophils produced much higher
levels of neutrophil extracellular traps (NETs). Based on these novel findings, we hypothesize that CIRP
induces NET-forming ICAM-1+ neutrophils to cause ALI in sepsis. We also showed that C23, a peptide derived
from human CIRP, dose-dependently inhibits CIRP-induced release of TNF-α and inhibits CIRP induction of
ICAM-1+ neutrophils. Thus, we further hypothesize that C23 attenuates sepsis-induced ALI by reducing CIRP-
induced NET-forming neutrophils. We will first demonstrate CIRP's induction of NET-forming ICAM-1+
neutrophils and their deleterious effects, both in vitro and in vivo. Next, we will identify key signaling pathways
through which CIRP induces NET-forming ICAM-1+ neutrophils. Finally, we will examine C23's ability to
suppress NET-forming ICAM-1+ neutrophils, decrease sepsis and ALI severity, and increase sepsis survival.
These studies will improve our understanding of how CIRP induces NET-forming neutrophils to cause
inflammation and tissue injury and support the development of C23 as a new and effective treatment for
patients with sepsis and ALI.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT: CIRP is an inflammatory mediator causing lung injury in sepsis, a common and highly lethal disease for which there is no FDA-approved treatment. We have discovered that CIRP increases the numbers of particularly damaging white blood cells, NET-forming ICAM-1+ neutrophils. In this proposal, we will elucidate the mechanism through which CIRP increases these cells to cause inflammation and injury during sepsis, and investigate the beneficial effects of a CIRP inhibitor as a new treatment for patients with sepsis and acute lung injury.